Botswana-Harvard T.H. Chan School of Public Health AIDS Initiative Partnership CTU Y18 Supplement

Project Summary/Abstract
The Clinical Trials Unit (CTU) in Botswana conducts research related to adult and pediatric HIV
therapeutic strategies; interventions to address HIV-associated infections/conditions in pediatric and
maternal populations; treatment and prevention of tuberculosis in adults (including pregnant women) and
children with and without HIV; and integrated HIV prevention strategies in pediatric and adult
populations.
These activities occur through participation in three research networks: 1) the ACTG; 2) IMPAACT, and
3) HPTN. We perform multi-center studies at our two established CRSs: one in Gaborone (all 3
networks), the capital city of Botswana, and the other in Molepolole (IMPAACT network only), the largest
village in Botswana. We thus work with both urban and village populations of all ages and of both sexes.
The primary objective of this CTU project in Botswana is to participate in and and contribute to the
following high-impact areas of research:
• Novel and durable treatments for HIV in adults (including pregnant women) and children
• Strategies to induce ART-free HIV remission (or eradication) in adults and children
• Treatment and prevention of HIV-related complications and co-infections in adults and children
• New treatments / modalities and prevention approaches for tuberculosis in adults and children
• HIV prevention strategies, including pre-exposure prophylaxis and integrated prevention approaches
Within each of these research areas, this CTU will contribute significantly to:
• Enrolling participants into and conducting high-quality clinical research studies,
• Participating in network activities, including protocol teams and scientific / resource committees, and
• Conceiving and proposing new, relevant, high-impact studies in priority areas

Public health relevance
Project Narrative The Botswana Clinical Trials Unit will develop and study strategies for preventing and treating HIV infection and HIV-related illnesses, including tuberculosis, that are relevant to the severe HIV epidemic in sub-Saharan Africa and elsewhere. This will include studies of novel and durable HIV treatment in HIV-infected adults, including pregnant women, and children; strategies to induce antiretroviral-free HIV remission (or eradication) in adults and children; new treatments and prevention approaches for tuberculosis in adults, including pregnant women, and children; and HIV prevention strategies, including pre-exposure prophylaxis and integrated prevention approaches.